Insulin-accelerated surgical approach to pre-retinal gene therapy

Project Summary/Abstract
Inherited retinal disease (IRD) represents a molecularly heterogenous group of chronic blinding conditions that
impact 5.5 million people worldwide, stemming from mutations in over 240 genes. The retina spans from the
anterior barrier of inner limiting membrane (ILM) to the light-sensing photoreceptors posteriorly. The retina is
positioned immediately anterior to the retinal pigment epithelium (RPE), which is critical for recycling the light-
sensitive opsins in the apposed retinal photoreceptors as well as for paracrine support. Recently, the RPE has
been elegantly shown to produce insulin locally, nearby the retina, which itself is rich in insulin receptors.
Voretigene neparvovec (Luxturna) was the first FDA approved gene therapy for IRD treatment, treating patients
with homozygous mutations in RPE65, but constituting just 0.5% of IRD patients. It works by introducing a
functioning copy of RPE65 with an adeno-associated virus (AAV) injection under the retina. This creates a
temporary retinal detachment but penetrates the anterior ILM barrier and focusses gene transduction in the
RPE, where RPE65 primarily functions. Despite its initial success, considerable doubts remain in the field as
many patients are challenged by ongoing chronic retinal/RPE atrophy in the area of subretinal bleb formation
for AAV administration, causing subsequent treatment failure after initial success. Two proposed failure
mechanisms include (1) immune response to residual vector, and (2) physical shearing forces on diseased and
delicate photoreceptors during retinal detachment creation with subretinal delivery of AAV. Thus, the aims of
the enclosed grant are constructed to test a novel AAV administration approach that combines both a pre-
retinal (rather than subretinal) approach with adjuvant insulin administration to accelerate uptake of AAV into
retinal cells. In this way, we propose that AAV uptake into retinal cells can be accelerated to the order of
minutes, allowing for removal of residual AAV after transduction during surgery, avoidance of intentional retinal
detachment, and prevention of inflammation from residual AAV. If successful, this gene agnostic approach
could be quickly adopted to treat virtually any inherited retinal disease, and extended to nonviral approaches
for larger genes.
These studies will be carried out with strong support of the Ohio State Gene Therapy Institute and Department
of Ophthalmology. The two lead mentors are R01 holding experienced principal investigators, with decades of
experience directing laboratories that focus on retinal cell biology and central nervous system gene therapy,
respectively. They have each successfully mentored multiple junior faculty members to R01 NIH funding. With
their targeted mentorship and that of a separate Advisory Team, as well as educational coursework and
intentional integration into the scientific community, support from this K08 will help transition Dr. Mendel from
retinal cell biologist and surgeon to expert retinal gene therapy investigator.

Public health relevance
Project Narrative Inherited retinal diseases represent a molecularly heterogenous group of chronic blinding conditions that impact 5.5 million people worldwide, stemming from mutations in over 240 genes. Current treatment with subretinal gene therapy raises significant concerns for damage to thin atrophic retinas, as well as inflammatory and long-term durability questions, causing a significant barrier to initial success with this approach. We propose to deliver gene therapy to the anterior of the retina, after removal of vitreous and inner limiting membrane barrier, and assist in rapid uptake into photoreceptors with coadministration of intraocular insulin.